Data Coordinating Center for the Type 1 Diabetes in Acute Pancreatitis Consortium

ABSTRACT
Type 1 diabetes mellitus (T1D) may develop after, or as a consequence of, one or more acute pancreatitis
episodes. Elucidation of early biomarkers, clinical signs, biomarkers of disease progression, immune and
genetic risk factors, most susceptible subgroups, precipitating mechanisms, etiology of acute pancreatitis, and
associated pathophysiology of the T1D can help inform best practices in treatment for reducing incidence of
T1D onset. In response to the National Institute of Diabetes and Digestive and Kidney Diseases’ RFA-DK-19-
023, the Departments of Public Health Sciences (DPHS) and Medicine (Endocrinology and Gastroenterology)
at The Pennsylvania State University College of Medicine and the Allegheny Health Network propose to serve
as the Data Coordinating Center (DCC) for the Type 1 Diabetes in Acute Pancreatitis Consortium (T1DAPC).
One DCC and 10 Clinical Centers (RFA-DK-19-022) will form the clinical consortium, T1DAPC. An efficient and
supportive DCC not only collaborates on development of all documentation and provides efficient statistical
analyses and Trial Master File, the results from the DCC form the backbone of numerous publications,
preliminary data for subsequent trials, and may lead to profound novel insights from ad-hoc, post-hoc, and
newly formulated analyses to Questions arising during the study. DPHS has vast experience and expertise as
the DCC for 10 NIH-funded clinical trial and five observational study research networks, which resulted in more
than 200 publications, six subsequent grants. Our vast experience in DCC for HIPAA-compliant data
compilation and analyses of multicenter clinical trials spans more than a dozen therapeutic areas and can
provide additional insights for analysis of ethnically and geographically diverse population of subjects as well
as development and analyses of distinct and overlapping clinical profiles, some being instituted post hoc with
development and testing cohorts. The DCC will aggregate and analyze all common data elements and
samples and provide scientific infrastructure and administrative support in a clear, concise, friendly manner for
the T1DAPC Consortium. The DCC and the Clinical Centers will form multi-disciplinary teams that execute a
prospective longitudinal observational study that can determine the incidence of T1 diabetes associated with
an acute pancreatitis episode and assess relationships with potential early biomarkers, clinical signs,
biomarkers of disease progression, immune and genetic risk factors, most susceptible subgroups, precipitating
mechanisms, etiology of acute pancreatitis, and associated pathophysiology of the T1D or other types of
diabetes. The DCC will collect, synthesize, and disseminate main findings and lessons learned from the
T1DAPC parent and ancillary studies, create public data sets, and share the biological samples in accordance
with the NIDDK and T1DAPC.

Public health relevance
PUBLIC NARRATIVE Acute pancreatitis is an acute inflammatory process resulting in damage to pancreatic parenchyma with an annual incidence ranging from 5 to 45 cases per 100,000 persons. Recent studies indicate that  30-40% of patients develop diabetes mellitus or impaired glucose tolerance within three to four years of even a single episode of acute pancreatitis  the autoantibodies associated with Type 1 diabetes (T1D) are found in people with a history of pancreatitis, indicating that pancreatitis-related diabetes poses long-term burden and significant risk of comorbidities as frequently as in other patients with diabetes The Type 1 Diabetes in Acute Pancreatitis Consortium (T1DAPC) will investigate the incidence, etiology, and pathophysiology of diabetes following acute pancreatitis with an emphasis on the auto-immune processes that result in T1D as well as the incidence, time course, and relationship to pancreatitis severity, the roles of pancreatitis etiology, genetic and genomic risk factors, environmental and biological factors, and potential biomarkers for the development of T1D.